Mechanistic and structural insights into a new pro-metastatic collagen glucosyltransferase

Lung cancer is the primary cause of cancer death in western countries, including the United States.
Kentucky leads the nation both in lung cancer incidence and mortality. Lung cancer-related mortality is mainly
due to metastasis. During metastasis, malignant tumors accumulate collagen fibrils to drive cancer cell
dissemination and impede the influx of anti-tumor immune cells. The long-term goal of our laboratory is to
determine the roles of collagen and collagen-modifying enzymes in metastasis to inform new therapeutic
development. Toward that goal, we found that the collagen lysyl hydroxylase 2’s long alternatively spliced
isoform b (LH2b), carrying an extra motif encoded by exon 13a, is a previously undetected collagen
glucosyltransferase (GGT). GGT plays a major role in LH2’s pro-metastatic activity. High expression levels of
LH2b predict a worse prognosis, while the expression levels of LH2’s short alternatively spliced isoform a
(LH2a) without exon 13a are not prognostic. These findings provide a novel basis for the observation made by
our group and many others that high LH2 expression has poor-prognostic value and drives the growth and
metastasis of multiple cancer types, including lung cancer, breast cancer, and sarcoma. Thus, LH2 GGT is a
new therapeutic target of interest. However, how LH2 GGT drives cancer metastasis is unclear and LH2 GGT
inhibitor is not available, deficiencies that can be addressed only by gaining mechanistic insight into the
structure-function of LH2 GGT.
To elucidate how LH2 GGT enzymatic activity is structurally regulated, we solved 3 collagen GGT
structures, including LH2 GGT and its mimiviral homolog. Our results suggested that LH2b forms a dimer with
a continuous collagen-binding site and binds UDP-glucose cooperatively. Based on these findings, we
hypothesized that LH2b’s unique structural features allow it to modify tumor stroma and drive metastasis. By
testing this hypothesis, we will gain insights into 1) to what extent LH2b overexpression and LH2b-mediated
collagen glucosylation happen in human lung cancer; 2) why LH2b drives tumor progression; 3) how LH2b
GGT function is regulated; 4) what are LH2b GGT’s pro-metastatic structural features. The findings from this
work will advance the understanding of the relevance and mechanism of LH2b in tumor progression and
identify the structural features of LH2b GGT that drive cancer progression. Such insights will inform LH2b GGT
cancer biology and inhibitor development.

Public health relevance
We recently found that high expression of the collagen-modifying enzyme lysyl hydroxylase 2 (LH2) drives lung cancer metastasis due to a previously undetected collagen glucosyltransferase (GGT) activity. Based on our new mechanistic and structural insights into LH2 GGT’s pro-metastatic activity, we hypothesize that the unique structural features of LH2 GGT underlie its pro-metastatic activity. If our hypothesis is proven true, these findings will inform LH2b GGT inhibitor development and could have broad clinical applicability because LH2 has been implicated in the metastasis of multiple cancer types.